Yale Center for Metabolic Phenotyping in Live Models of Obesity and Diabetes

The overarching goal of the Yale MPMOD is to provide extramural investigators access to the unique metabolic
phenotyping services provided by the Yale MPMOD and empower them to harness the power of mouse genetics
to its fullest potential to metabolically phenotype their mouse models of obesity and diabetes. The Yale MPMOD
consists of three highly interactive Cores that have an established (>20 yr) track record of working together in
close harmony: 1) The Yale MPMOD Administrative Core oversees the operation of the Yale MPMOD,
facilitates research with the other MPMOD Centers and the MPMOD Coordinating Unit to standardize key
methodologies, and coordinates the efficient workflow through the Yale MPMOD cores and access to the Yale
MPMOD Animal Core and the Yale MPMOD Phenotyping Core, 2) The Yale MPMOD Animal Core provides
a centralized facility for coordinating receiving, screening and monitoring mice from outside investigators and 3)
The Yale MPMOD Phenotyping Core empowers Yale MPMOD clients with access to unique metabolic phenotyping
services that provides them with the means to characterize the metabolic changes in their particular mouse models
of complex metabolic disease using established state-of-the-art methodology. The Specific Aims of the Yale
MPMOD are to: 1) serve the US academic research community to study diabetes and obesity in their mouse
models by providing metabolic, physiologic, and behavioral phenotyping on live mice, as well as expert advice
in mouse models, experiment design, data analysis, and data interpretation at similar cost whether inside or
outside Yale without bias and, and collaborate to provide a wide array of tests and expert advice while avoiding
unnecessary overlap, 2) Establish a Yale MPMOD Vibrant Program, which will work with the other national
MPMODs and the MPMOD Coordinating Unit to promote health equity and diversity in the US biomedical
research enterprise by supporting underrepresented minority investigators to succeed in biomedical research in
the areas of diabetes and obesity, via resources such as test services, pilot funding, expert advice on
experimental design, and/or short internships at the Yale MPMOD to learn test technologies, 3) Promote rigor
and reproducibility in research by: a) developing and sharing validated protocols for phenotyping live mice; b)
providing difficult experimental tests conducted by experts with a high degree of standardization and quality
control, to PIs who would otherwise not be able to conduct or afford them; and c) sharing technologies and
providing web-based tools for gold-standard approaches in experimental methods and data analysis, 4). Develop
standardized data formats and storage guidelines for complex data, including metadata, for sharing with clients
and the public as appropriate, and employ unique Research Resource identifiers (RRID), Digital Object
Identifiers (DOI), and other best practices directed by DKNet.

Public health relevance
Project Narrative The overarching goal of the Yale Metabolic Phenotyping in Liver Models of Obesity and Diabetes Center (Yale MPMOD) is to provide extramural investigators access to the unique metabolic phenotyping services provided by the Yale MPMOD and empower them to harness the power of mouse genetics to its fullest potential to metabolically phenotype their mouse models of obesity and diabetes.